Enhancing shared decision-making to prompt and guide individualized care for people with Alzheimer's Disease and Diabetes

PROJECT ABSTRACT
This Mentored Research Scientist Career Development Award (K01) will support my pursuit of becoming an
independently funded investigator in Alzheimer’s and aging research. My proposal features a systematic
approach to a comprehensive training plan including mentorship, didactic and experiential learning activities,
and professional development opportunities, as well as a complementary research project establishing
foundational evidence for my research agenda centered on improving care of people with Alzheimer’s disease,
related dementias, and diabetes mellitus (ADRD-DM). My training goals are designed to attain essential
advanced knowledge and skills pertaining to 1) ADRD collaborative care and research, 2) DM collaborative
care and research, and 3) health systems and clinical trials. My research and training will take advantage of
the immense resources and expertise at supporting centers across Indiana University, the Regenstrief
Institute, and Eskenazi Health, including the National Institute on Aging-funded Institute of Alzheimer’s Disease
Research Center and the IMPACT Collaboratory, and will be conducted under the mentorship of a
multidisciplinary team of ADRD, DM, and implementation science experts, who have clinical and research
experience in creating innovative technologies to improve care delivery in ADRD-DM populations. Building on
my expertise in human factors engineering, the research project will examine how use of information
technology can increase awareness of hypoglycemia and shared decisions about treatment options among
people with ADRD-DM and their caregivers and primary care clinicians. I will use a participatory design
process to develop assistive information technology that leverages continuous glucose monitoring devices. In
this experiential learning opportunity, I will gain insights into patients’ and caregivers’ perceptions and
experiences, clinicians’ information gaps and other barriers to individualizing ADRD-DM treatment, and the
design of technology to facilitate shared decision-making, while expanding the knowledge base on these
aspects of health care. Furthermore, I intend to increase representation of diverse socioeconomical and
cultural backgrounds among ADRD research participants and scientists. This K01 award will uniquely position
me to bring together human factors and ADRD-DM research to design and implement technology to assess
and improve the health of people with ADRD.

Public health relevance
PROJECT NARRATIVE People with Alzheimer’s Disease, related dementias, and diabetes have a notably higher risk of hypoglycemia and adverse events, including hospitalization and death. This project’s goal is to increase awareness of hypoglycemic risks and shared decisions about treatment options among patients with ADRD-DM, caregivers, and primary care clinicians. To that end, I will design an assistive information technology leveraging continuous glucose monitoring and evaluate its impact on care.